Impacts of the Pennsylvania Rural Health Model on Health Care Access and Utilization

ABSTRACT
More than 130 rural hospitals in the U.S. have closed over the past decade, exacerbating challenges that residents in rural areas face accessing care and contributing to differences in health outcomes. The Pennsylvania Rural Health Model (PARHM) is a novel alternative payment model (APM) intended to ensure the financial viability of rural hospitals, increase access to high-quality hospital services, and improve population health in rural areas. The two main components of PARHM are global budgets and hospital-specific transformation plans. Global budgets are prospective payments made by payers to cover all inpatient and hospital-based outpatient services. Global budgets decouple hospital revenue from volume, as currently exists under fee-for- service payment, and therefore incentivize the efficient use of medical services and promote reduction of avoidable hospitalizations. Through transformation plans, hospitals develop plans to tailor services to the needs of their patients. The goal is to make meaningful improvements in the quality of the care hospitals provide and address the most pressing health needs in these areas to improve population health and realize future savings. Hospitals joined PARHM in cohorts over three years. We leverage variation in implementation of PARHM and a within-state control group of eligible but non-participating hospitals to evaluate the effects of PARHM using a difference-in-differences design to compare differences in trends. We propose the following aims: Aim 1. Examine the association of PARHM with rural hospitals’ provision of traditionally unprofitable service lines and patient use of those services. We hypothesize that treated hospitals will be more likely to continue offering selected hospital service lines that are of particular significance to rural areas and have traditionally been considered unprofitable (e.g., obstetrics). Furthermore, we hypothesize that utilization rates for these services will increase more in treated vs. control groups. Aim 2. Assess the impact of PARHM on rates of potentially avoidable hospitalizations (PAHs) for ambulatory care sensitive conditions. We hypothesize that PAH rates will decrease more in treated vs. control groups as a result of improved ambulatory care coordination and financial incentives. Overall, this study will address the current gap in the literature regarding PARHM on health outcomes and global budgets on hospital service lines. This project will provide novel evidence about how global budgets affect access to hospital services and health outcomes in rural communities—critical for evaluating PARHM’s performance and informing future payment models targeted to NIHMD communities. Completion of this project and the associated training goals will provide the PI with training to become a physician-scientist with the training and skills to critically evaluate and inform payment and health care delivery policy for rural areas in the United States.

Public health relevance
PUBLIC HEALTH RELEVANCE Through global budgets and hospital-specific transformation plans, the Pennsylvania Rural Health Model (PARHM) has the potential to improve rural health by improving the financial viability of participating hospitals and incentivizing improvements in the health of rural populations. The proposed research aims to determine PARHM’s impact on the provision of traditionally unprofitable hospital service lines, the change in utilization rates of those services, and the change in rates of potentially avoidable hospitalization in hospital service areas. Our results will help determine the success of PARHM and inform the design and implementation of future alternative payment models in rural settings.